Protein & Small Molecular Chemistry

CORE C. PROTEIN AND SMALL MOLECULE CHEMISTRY
The role of the Protein and Small Molecule Chemistry Core is central to the needs of all the investigators in the
Program Project Proposal. The Core will provide project investigators access to purified proteins and virus-like
particle (VLPs) as well as custom synthesis of small molecules, peptides, and bile acids. The Core will also
construct protein expression plasmids as well as mutant versions of proteins by site-directed mutagenesis as
needed by investigators. Finally, the Core will characterize and quantitate protein-protein and protein-ligand
interactions. Examples of Core activities include purification of norovirus protease to facilitate drug discovery
and purification of VLPs for investigations of antibody interactions with capsid. Activities also include synthesis
of small molecule protease inhibitor candidates for biochemical and cell-based testing as well as structural
studies. Further, the Core will synthesize fluorescently-labeled bile acids for studies of norovirus infections and
propagation. In addition, the Core will measure binding affinity of small molecules with norovirus protease as
well as affinity of antibody-VLP interactions and other protein-protein interactions as needed by project
investigators. The Core personnel have extensive experience in the methods required for providing these
services and all of the equipment and resources necessary are available in the Core. The performance of
services such as protein purification and small molecule synthesis, mutagenesis, and binding measurements in
a Core facility avoids the need for individual investigators to acquire the necessary expertise and equipment
and is an efficient means of facilitating progress on the scientific goals of the project.